Insulin Receptor Structure and Turnover

Abstract
This is a renewal of NIH grant DK031036, the original grant to the Kahn lab, which is now in its 38th year
and was granted MERIT status at the last renewal. Since inception, this grant has focused on the insulin and
IGF-1 receptors, their signaling pathways and their alterations in physiologic and pathologic states. Over the
past decade, we have made tremendous progress in understanding the signaling and biological roles of these
receptors through both in vitro and in vivo studies. These include extensive studies using gene targeting to
create single and combinatorial knockouts of insulin and IGF-1 receptors (IR and IGF1R); combinatorial
knockouts IR with post-receptors effectors of insulin action (IRS and FoxO proteins); and tissue-specific and
inducible knockouts to determine the role of IR and IGF1R in individual tissues in normal physiology and the
pathophysiology of diabetes. In addition, in vitro we have defined differential signaling by insulin and IGF-1
receptors, and unique actions of insulin and IGF-1 in different cell types. As a result, since the last competitive
renewal, this grant has provided support for 88 published papers which have led to new insights into the
complex nature of the insulin/IGF-1 signaling network, the contribution of insulin resistance in different organs
to diabetes and metabolic syndrome, as well as evidence on how tissues communicate with one another in
insulin resistant states. In addition, we have made novel observations regarding the role of insulin action in
non-classical target tissues, like the brain, intestine, endothelial and iPS cells; the presence of novel insulin-like
peptides in viruses, and potential for signaling by unoccupied IR and IGF1R. During the coming grant period,
our aims are to continue to expand our understanding of insulin/IGF1 action by 1) defining the differential roles
of the extra- and intra-cellular domains of IR and IGF1R in signaling in vitro and in vivo using three
complementary strategies [mass spectroscopy based phosphoproteomic analysis of insulin/IGF-1 receptor
mutants and chimeric receptors in vitro; creation of a new generation of knock-in mouse models in which IR is
replaced by IGF1R, by chimeric insulin/IGF-1 receptors or by substitutions in the juxtamembrane domain of the
receptor important in differences in IR vs IGF1R signaling, and use of newly discovered viral insulin-like
peptides (VILPs) to explore differences in IR/IGF1R signaling]; 2) determine the nature of signaling by the
unoccupied insulin and IGF-1 receptors involved in control of gene expression, autophagy and apoptosis and
identify the domains of the receptors mediating these effects and the signaling proteins that interact with them
and 3) continuing to define the role of insulin signaling in brain on astrocytes vs neurons using global and
region-specific IR knockouts; insulin regulation of gene expression and metabolite levels in brain; and the
interaction of insulin resistance in brain with genetic risks in pathogenesis of Alzheimer’s Disease. Together
these studies will continue to help unravel new aspects in the mechanisms of insulin/IGF-1 receptor signaling
and their alterations in diabetes, metabolic and neurodegenerative disease.

Public health relevance
Narrative This is a renewal of NIH grant DK031036 which is focused on the insulin and IGF-1 receptors, their signaling pathways and their alterations in physiologic and pathologic states. Over the past decade, we have made tremendous progress in understanding the signaling and biological roles of these receptors through both in vitro and in vivo studies, including extensive studies using gene targeting to create over a dozen models with single, combinatorial and tissue-specific knockouts of insulin and IGF-1 receptors to determine their role in normal physiology and the pathophysiology of disease. During the coming grant period, our aims are to continue to expand our understanding of insulin/IGF1 action by 1) defining the differential roles of the extra- and intra-cellular domains of IR and IGF1R in signaling in vitro and in vivo; 2) determining the nature of signaling by the unoccupied insulin and IGF-1 receptors involved in control of gene expression, autophagy and apoptosis and 3) continuing to determine the role of insulin signaling in brain on astrocytes vs neurons and the role insulin resistance in brain in pathogenesis of Alzheimer’s Disease.